IDALS/FDA AFRPS Maintenance with PC Regulatory Activities

Project
Summary
Our focus will be on two separate, but related goals. The first goal will be to maintain our
compliance with the Animal Feed Regulatory Program Standards (AFRPS) and to improve our
processes under the AFRPS standards by developing policies and procedures, strengthening
collaborations, and conducting program self-assessment to maintain and improve conformance
with the standards. The second goal will be to implement the PCAF regulations at the Iowa
Department of Agriculture and Land Stewardship. This will require reviewing (and possibly
revising) our current code and laws to make them conform to the PCAF regulation, training
inspectors on the requirements (and developing a training program so that future inspectors will
continue to be adequately trained), and developing and conducting an Out Reach program to
help producers to understand their responsibilities under the new regulation. Meeting these
combined goals will help the Commercial Feed and Fertilizer Bureau to protect public health by
having policies and procedures in place resulting in a high quality animal feeds regulatory
program.

Public health relevance
Project Narrative Our dual focus will be to maintain our compliance with the Animal Feed Regulatory Program Standards (AFRPS) and to improve our processes under the AFRPS standards and to implement the PCAF regulations at IDALS. This will require reviewing code to, developing a training program, and developing an Out Reach program to help producers to understand their responsibilities under the new regulation.